Spinning disk confocal for a core facility

Project Summary
A Yokogawa CSU-W1 SoRa spinning disk confocal microscope on an inverted Nikon
microscope stand is requested for a heavily used core facility. The proposed instrument
would address our needs to acquire large fields of high-resolution confocal data at high
speeds, reduce photodamage of living cells, and resolve molecular level events. Not
only would these new capabilities be vital for multiple live-cell/tissue studies, it would
also replace our existing spinning disk confocal, which is obsolete. In our tests, the
SoRa confocal revealed subcellular features of living cells not visible with other
commercial super-resolution or confocal microscopes. The instrument's unique
combination of exceptional signal to noise performance, large field of view, speed of
imaging, and ease of use will provide an order of magnitude superior performance and
support key NIH-funded projects.

Public health relevance
Project Narrative Because cell and tissue functions are spatially regulated by dynamic processes, fast and sensitive microscopy is required to unravel the interplay of normal, mutant, and disease-causing processes. The superior performance of the proposed equipment exceeds those of our current equipment and will enable investigators to efficiently discover and probe cell functions.